RPE PFKFB3 in subretinal fibrosis

PROJECT SUMMARY
Subretinal fibrosis, an end-stage fibrous plaque/disciform scar that progresses from choroidal neovascularization
(CNV) of neovascular age-related macular degeneration (nAMD), compromises highly organized anatomical
layers and tightly coordinated cellular interactions, inevitably leading to irreversible visual impairment. Current
treatment for subretinal fibrosis is limited; thus, therapeutic strategies for the inhibition of subretinal fibrosis are
essential.
Many types of cells, including retinal pigment epithelium (RPE) cells, contribute to subretinal fibrosis by
differentiating into mesenchymal-like cells, α-smooth muscle actin-positive myofibroblasts and/or producing
profibrotic and proinflammatory factors. However, the underlying metabolic mechanisms for these cellular and
molecular activities are not well defined. Glycolysis is a metabolic pathway utilized by many proliferative cells.
my preliminary data show that cells in subretinal fibrotic areas are hyper-glycolytic, as evidenced by increased
expression of glycolytic enzymes and glycolytic regulators/activators including 6-phosphofructo-2-
kinase/fructose-2, 6-bisphosphatase isoform 3 (PFKFB3), a critical enzyme for activation of glycolysis in various
highly proliferative cells. PFKFB3 catalyzes the synthesis of fructose-2,6-bisphosphate (F2, 6P2), which is the
most potent allosteric activator of 6-phosphofructo-1-kinase (PFK-1), a rate-limiting enzyme for glycolysis. I have
found that high levels of glycolytic enzymes including PFKFB3 are present in the RPE/choroid complex isolated
from laser-induced subretinal fibrosis in C57BL/6j mice, spontaneous lesion in very low–density lipoprotein
receptor deficient (Vldlr-/-) mice and RPE layer of nAMD patients. Furthermore, I have also observed that the
area of subretinal fibrosis is markedly decreased in Pfkfb3+/- mice. My in vitro studies have shown that PFKFB3
knockdown in RPE cells inhibits their transition to mesenchymal and reduces their production of proinflammatory
and profibrotic factors. I hypothesize that PFKFB3-mediated glycolysis in RPE cells induces their transition to
mesenchymal cells and their production of profibrotic and proinflammatory factors by activating HIFs pathways,
eventually leading to the development of subretinal fibrosis. To test my hypothesis, I have generated RPE-
specific Pfkfb3-deficient mice and established mouse subretinal fibrosis models with laser-induced CNV and
spontaneous CNV in Vldlr-/- mice. I will investigate the effect of Pfkfb3 deficiency in RPE cells on subretinal
fibrosis using specific genetic tools with an integrated approach of in vivo and in vitro models. My study will define
the role of PFKFB3-mediated metabolism in RPE cells in the development of subretinal fibrosis and demonstrate
PFKFB3 inhibition as a novel strategy for the treatment of subretinal fibrosis.

Public health relevance
PROJECT NARRATIVE This proposal seeks to develop a new molecular strategy to limit subretinal fibrosis in blinding eye disease. PFKFB3 (6-phosphofructo-2-kinase/fructose-2, 6-bisphosphatase isoform 3) is a critical regulator/activator of glycolysis. The proposed studies are designed to use Pfkfb3 deficient mice and PFKFB3 knockdown/overexpressing RPE cells to investigate the involvement of glycolysis in RPE cells in subretinal fibrosis and to define the underlying mechanisms.